Hypoxia morphology of Aspergillus fumigatus impacts diagnostics

Aspergillus fumigatus (Af) is a common environmental mould that can cause high-mortality mycoses, such as
Invasive Pulmonary Aspergillosis (IPA). Disease caused by A. fumigatus has remained significantly difficult to
diagnose due to physical limitations of sample collection and limited diagnostic methods, meaning Af-mycoses
are often not definitively, if ever, diagnosed until disease has progressed to a severe state. Contemporary
clinical diagnosis of A. fumigatus disease relies on non-culture-based methods of organism detection including
Platelia and FungiTell microplate assays to detect fungal galactomannan antigen and beta-glucans
respectively. However, the extent to which heterogeneity in A. fumigatus clinical isolates impacts disease
diagnosis has not been studied. Numerous clinical observations over the years strongly suggest significant
heterogeneity in A. fumigatus morphologies that I hypothesize impacts diagnostic results. Our lab has
previously identified that increased expression of a subtelomeric gene hrmA via SNP D304G (strain: HrmAREV)
is sufficient to induce a clinically observed hypoxia-fit morphologies (H-MORPH) of A. fumigatus. H-MORPH is
clinically relevant as strains exhibiting this morphology can be isolated from patients, however it remains
unknown how this morphology impacts the ability to detect and diagnose IPA. My preliminary data suggests
that the lab-generated H-MORPH HrmAREV exhibits increased levels of both beta-glucan and galactomannan
antigens compared to isogenic N-MORPH strains in vitro. My central hypothesis is that H-MORPH isolates will
result in the increased ability to detect and diagnose IPA both in vitro and in vivo. To address this central
hypothesis, I will pursue the following two aims: 1.) I will test the hypothesis that the H-MORPH associated
gene, hrmA, regulates antigenic extracellular polysaccharide composition, and 2.) I will test the hypothesis that
HrmA induction increases the ability to diagnose in vivo infection using contemporary clinical diagnostic
markers. As we have previously identified that HrmA has a weakly predicted RNA recognition motif (RRM) I
hypothesize HrmA mediates the alteration of the extracellular polysaccharide profile through post-
transcriptional RNA modulation, which I will probe with targeted RNA immunoprecipitation. After determining
the extracellular polysaccharide composition, I will use N- and H-MORPH strains in vitro and in vivo to
determine how morphology impacts detection using clinical diagnostic Fungitell and Platelia microplate assays.
In my approach, I will combine genetics, biochemical assays, and clinical microbiology diagnostic assays to
determine the role of HrmA in A. fumigatus clinically relevant diagnostic antigen production. Overall, the
experiments outlined in this proposal will identify a role for the fungal specific gene, hrmA, in modulating fungal
biology through translational implications of disease as it relates to a clinically relevant morphotype of A.
fumigatus, while providing me with important pre-doctoral training in fungal genetics, biochemistry,
bioinformatics, and clinical microbiology.

Public health relevance
Project Narrative The aim of this proposal is to investigate the role of the unique hypoxia-locked morphology (H-MORPH) of Aspergillus fumigatus in both altering the antigenic extracellular polysaccharide matrix and subsequently the ability to detect and diagnose pulmonary infection. Mycoses caused by A. fumigatus are difficult to diagnose and while contemporary diagnostics have progressed towards non-culture-based methods, much of what we know about diagnostics has focused on normoxia fit morphotypes (N-MORPH), thus how H-MORPH impacts our ability to detect and diagnose disease is a significant gap in knowledge. As both N-MORPH and H-MORPH isolates are recovered from diverse patient populations with A. fumigatus pulmonary infections, understanding how and why H-MORPH strains impact our ability to diagnose disease will provide impactful knowledge to our understanding of A. fumigatus pulmonary mycoses.